Training Program in Environmental Medicine

DESCRIPTION (provided by applicant) Environmental agents play a significant role in the development of human disease. The identification of such toxicants and understanding their causal role in disease can rapidly be used in risk assessment and management and holds enormous promise in terms of therapeutic and clinical scenarios. This application requests funds to continue NYU's training program in environmental and molecular toxicology. The training will address a broad spectrum of problems in environmental health, from the causative molecular mechanisms of cancer, cardiopulmonary diseases, and other environmentally-related disorders to the development of animal models which may be used for predicting the adverse effects of environmental agents on human health. The major strength of the proposed toxicology training program is the outstanding quality and diversity of the training faculty, which will provide 4 pre-doctoral and 2 postdoctoral trainees an excellent opportunity to conduct environmental and molecular toxicology research in laboratories of investigators with international reputations. The mission of this training program is to development creative and independent research scientists who can address the complex problems presented by exposure to environmental toxicants.